IP24-017 - Collaborative research on influenza and other respiratory pathogens in South Africa

PROJECT SUMMARY
This project aims to generate a body of data that will result in improved approaches for disease
surveillance and prevention and expanded access to interventions for the reduction of morbidity and
mortality associated with influenza and other respiratory pathogens in South Africa and the African
region. Specifically (Objective 1, Project 1), we aim to expand and evaluate digital participatory
surveillance (DPS) in South Africa. If found to provide valid and useful data on trends in respiratory
illness and health-seeking behavior, we will expand this platform in collaboration with neighbouring
countries with limited laboratory infrastructure and evaluate it as a system for monitoring seasonal
respiratory illness and identifying outbreaks in the African region. We will also (Objective 1, Project 2)
evaluate right-sizing for influenza genomic surveillance through an evaluation of whether the timing,
geographic and demographic distribution of influenza genomic sequence data affects the reported
dominance and diversity of circulating viruses to guide annual influenza vaccine composition. This will
have a training component to increase regional capacity for next generation sequencing and will
provide data to guide WHO and CDC on the optimum number and geographic distribution of sentinel
sites needed to facilitate public health decisions. As part of our strategy to strengthen the NICD’s role
as a national and regional influenza reference laboratory we will develop and implement influenza
microneutralization (MN) assays (Objective 1, Project 3). These assays will be used to better
characterize immune responses to influenza infection or vaccination, demonstrate the role of sero-
epidemiology for public health surveillance and enable testing of sera collected in vaccine trials. We
will also develop a high throughput influenza multiplex immunoassays (MIA) to characterize the
immune response to influenza infection and vaccination (Objective 1, Project 4). Once successfully
optimized this assay will be used to conduct antibody landscape studies from cohort participants in
the CDC-funded HUTS and PHIRST studies and evaluate vaccine trial participant responses. In future
years, these antibody landscape analyses, combined with high-resolution cohort data (including
infection and vaccination histories) and whole genome sequencing data from participants, will
generate foundational knowledge on population-level immune response and how this drives viral
evolution. The ultimate goal of this work would be to develop a framework in which population
serology data is incorporated into the WHO vaccine strain update process. We will conduct a phase 2
double-blinded, randomized, controlled trial to evaluate the vaccine efficacy, safety, and
immunogenicity of a seasonal inactivated influenza vaccine and a comparator vaccine, in healthy
South Africans (Objective 2, Project 5). This study will aim to understand the mechanism by which
different influenza vaccines prevent illness and the potential impact of different vaccines on onward
transmission. Ultimately this would be part of a roadmap to ensure increased access to influenza
vaccines in Africa. Lastly (Objective 3, Project 6), we aim to scale up and maintain increased influenza
uptake among groups at increased risk of severe influenza illness by understanding the drivers of low
influenza vaccination uptake and challenges in current influenza vaccination campaigns, and
implementing strategies targeted at these drivers.

Public health relevance
PROJECT NARRATIVE This project will provide critical data to improve approaches to disease surveillance in Africa and expand capacity for evaluation of influenza immune responses. It will also provide data on the efficacy and mechanism of illness prevention of select existing and novel influenza vaccines and support interventions to scale up and maintain increased influenza vaccine coverage among high risk groups in South Africa and the region.